Transposon strategies to escape host silencing

PROJECT SUMMARY/ABSTRACT
Transposable elements (TEs), like viruses, are genetic parasites. They use their host’s cellular machinery to
replicate and must replicate faster than their host to avoid extinction. Replication of TEs in host cells causes
damaging mutations: TE insertions can inactivate host genes and cause chromosomal rearrangements. Host
genomes have therefore evolved sophisticated silencing pathways to identify TEs and suppress their
replication activity. However, active TEs remain present in the genomes of almost all eukaryotes. One
explanation for their persistence over evolutionary time is that, like viruses, TEs evolve rapidly to escape host
silencing, which in turn selects for an adaptive response from the host, thus locking TEs and their hosts into an
evolutionary arms race. Unlike viruses, whose immune evasion strategies have been well-studied, the
mechanisms by which TEs are able to escape host silencing are relatively unknown. The overall goal of our
research program is to understand strategies used by TEs to escape host silencing and how such strategies
affect host phenotypes and/or disease states.
Our research is currently focused on three such strategies: (1) Permissive niches for TE mobilization: one way
TEs can escape host silencing is by preferentially mobilizing in vulnerable cell types and/or being transcribed
highly enough to overwhelm host defenses. Our goal for this research direction is to identify novel permissive
niches and understand the mechanisms TEs use to gain expression in these cell types. (2) Host gene capture
by TEs: Drosophila telomeres are composed of specialized retrotransposons that replicate onto the
chromosome ends. These elements likely evolve in conflict with their host despite serving an essential cellular
function. We have identified telomeric retrotransposons in over 100 species of Drosophila and found that these
elements have repeatedly captured fragments of host TE silencing genes. Our goal for this research direction
is to understand this gene capture phenomenon and how it is used by TEs to evade host silencing. (3) TE
derepression in species hybrids: hybrid dysgenesis occurs in F1 progeny when a TE is present in the paternal
genome but missing from the maternal genome. Small RNAs that target such a TE are therefore unable to be
supplied to the embryo by the mother and the TE becomes hyperactivated in the progeny, usually resulting in
DNA damage, sterility, and gonadal atrophy. We have discovered a novel exception to this phenomenon where
a gypsy family TE is massively upregulated in F1 progeny without an obvious effect on fertility. This situation
provides a unique opportunity for studying post-transcriptional regulation of TE activity.

Public health relevance
PROJECT NARRATIVE The goal of this project is to understand how selfish genetic elements known as transposons are able to escape or evade silencing by specialized host pathways that target TE activity. This research is relevant to human health because almost half of the human genome is composed of transposons and transposons are major contributors to genetic variation among individuals. Understanding the biological functions of transposon- derived DNA is important for interpreting the human genome and inferring traits and disease risk from patient genotypes, thereby supporting the NIH’s mission to enhance health and reduce illness.